Long-term Suppressive Valacyclovir Treatment for Herpes Zoster Ophthalmicus

PROJECT SUMMARY:
The objective of the Zoster Eye Disease Study (ZEDS) is to determine whether prolonged
suppressive oral antiviral treatment with valacyclovir reduces complications of Herpes Zoster
Ophthalmicus (HZO), thereby improving clinical outcomes in this common and potentially vision-
and life-threatening disease. There are 1,000,000 new cases of Herpes Zoster (HZ) per year in
the USA, with 10-20% being HZO. The demographics of HZ and HZO are similar in Canada and
the US, with the exception that vaccination against zoster has substantially less insurance
coverage and usage in Canada. The first aim of this double-masked, placebo controlled
multicenter randomized clinical trial will test the hypothesis that suppressive antiviral treatment
for 12 months with oral valacyclovir 1000 mg daily reduces the rate of new or worsening
dendriform epithelial keratitis, stromal keratitis, endothelial keratitis or uveitis compared to
placebo, at 12 months as the primary endpoint, and at 18 months including 6 months of followup
after treatment, as the secondary endpoint, in patients with HZO who have had an episode of
one of these disease manifestations during the year prior to enrollment. The second aim is to
test the hypothesis that suppressive treatment for 12 months with oral valacyclovir 1000 mg
daily reduces the severity and duration of postherpetic neuralgia (PHN), compared to placebo,
at 12 months and at 18 months. PHN is a debilitating chronic pain syndrome that negatively
impacts quality of life, especially in elderly patients. Additional aims are to evaluate the impact of
vaccination against zoster on study outcomes and COVID-19, and relationship between COVID-
19 diagnosis and/or vaccination on onset of HZO.
The study will enroll immunocompetent patients age 18 years and older who have HZO
diagnosed at variable times in the past, with active keratitis and/or iritis within the past year.
Eligible patients will be randomized in a 1:1 ratio to long-term suppressive treatment with oral
valacyclovir 1000 mg daily or placebo for 12 months, plus usual ophthalmic care, and followed
every 3 months for a total of 18 months, to determine outcomes of new or worsening dendriform
epithelial keratitis, stromal keratitis, endothelial keratitis or uveitis and/or severity and duration of
PHN during 12 months of treatment and for 6 months following treatment discontinuation. The
results with regard to PHN may be applicable to HZ in other locations. If suppressive
valacyclovir treatment is determined to be effective, the potentially devastating disease burden
of HZO and HZ may be reduced for patients, as well as the annual costs to society, estimated in
the USA to be one billion dollars.

Public health relevance
Project Narrative Herpes Zoster Ophthalmicus (HZO), a form of herpes zoster (HZ), or shingles, affecting the eye, is a common and serious disease caused by reactivation of the chicken pox virus that can result in chronic eye disease and incapacitating pain. This study will determine if prolonged treatment with a low dose of the antiviral valacyclovir improves outcomes by reducing eye disease and/or chronic pain in HZO patients.